This service is for Micro Contract for DMPK SME services for BPN, HEAL and Biologics. Vendor is Ron Franklin.

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.